Origins and Benefits of Biologically Active Components in Human Milk

PROJECT SUMMARY
The 5th FASEB Science Research Conference (SRC) on “Origins and Benefits of Biologically
Active Components in Human Milk” in Melbourne, Florida, June 4-9, 2023, will be a gathering of
professionals who wish to deepen their understanding of this scientific topic. The conference will
bring together previous and new speakers/attendees to promote diversity of thought in this space.
The conference has a strong inter-disciplinary nature, with stakeholders from industry, academia
and government coming together to better understand human milk as a complex biological
system with the ultimate goal of improving maternal & infant health.
A majority of the conference sessions will address key scientific research themes and objectives
outlined in the NICHD Strategic Plan 2020: “Of unique interest to the institute [NICHD] is a better
understanding of the composition and function of human milk, the effect of maternal nutrition and
length of gestation on human milk composition and lactation, and the optimal source of nutrition
and mode if nutrient delivery to the infant, especially preterm infants.” In addition, the conference
addresses one of the ten aspirational goals in the NICHD Strategic Plan 2020: “Optimize infant
survival by synthesizing human milk, capturing all its components and properties, and
individualizing it to the characteristics of the infant’s mother.”
Understanding the origins and benefits of human milk components is also relevant to NIH
institutes other than NICHD as they affect gut health and development and metabolic diseases
(NIDDK) and protect from allergy and infectious diseases (NIAID). In fact, human milk
components may serve as templates for novel, safe and effective treatments for diseases in
people of all ages and, therefore, be of relevance to many of the other NIH institutes.
Finally, the conference will offer a strong “career development” focus, supporting students and
early career investigators with their professional ambitions. We therefore specifically aim to
subsidize registration and travel of invited speakers in the early career investigator category and
provide travel awards for students with outstanding abstracts, posters and oral presentations.
Supporting the next generation of researchers, clinicians and educators in the field of human milk
and lactation will ensure that NICHD’s current objectives and aspirational goals will be met not
only today, but also in the future.

Public health relevance
The 5th FASEB Science Research Conference (SRC) on “Origins and Benefits of Biologically Active Components in Human Milk” will bring together stakeholders from industry, academia and government to further advance human milk science through discourse and collaboration. It will proactively support diversity and student professional development. Sessions will include: (i) Mammary Gland Biology and the Origins of Human Milk Bioactives, (ii) Infant Immune Development and Maturation, (iii) Infant Brain development and Cognition, (iv) Special Session: Career Development, (v) Human Milk Oligosaccharides – Origins & Benefits, (vi) Special Session: Technology Development and Innovation, (vii) Milk Fat Globule Membrane, (viii) Special Session: Ensuring the Safety of Substances added to Infant Formula, and (ix) Big Data in Human Milk Research